A mechanistic and dyadic approach to identify how interpersonal conscientiousness supports cognitive health and lowers risk of dementia

Project Summary
The burden of Alzheimer’s Disease (AD) takes a significant toll on the individual living with dementia, their
families and communities, and the healthcare system. Without effective intervention and prevention strategies,
the prevalence of AD is expected to more than double over the next 30 years. It is critical to identify protective
factors that can be leveraged for more effective prevention before the onset of the disease. Conscientiousness
is a personality trait that is associated consistently with better health outcomes, which extends to dementia:
Conscientiousness is one of the most replicated psychological factors that is protective against cognitive
impairment. Most work on Conscientiousness has focused on its agentic aspects (e.g., self-control, achievement
striving). Conscientiousness, however, has a distinct interpersonal component that is often overlooked in the
relation with health in general and cognition in particular. This interpersonal component – Interpersonal
Conscientiousness – defined as either responsibility or dutifulness, is protective against dementia, an effect that
has replicated in three independent samples. In addition, its protective association with dementia is independent
of the agentic components of this trait and extends to cognitive function prior to dementia. Interpersonal
Conscientiousness is thus a robust and novel psychological factor that is a promising target of intervention for
healthier cognitive outcomes in older adulthood. The objective of this proposal is to provide much needed stage
0 evidence that is necessary for intervention development. Specifically, this research aims to identify the
clinical/physiological, behavioral, psychological, and relational mechanisms through which Interpersonal
Conscientiousness leads to better cognitive outcomes. The proposed research addresses these mechanisms
and cognition as typically measured in lab settings and the daily expression of these mechanisms and
momentary cognitive performance measured with ecological momentary assessment in everyday life. It seeks
to identify the pathways through which Interpersonal Conscientiousness protects cognition and promotes better
daily cognitive function across a critical period of the lifespan – midlife and the transition to old age (ages 40-70)
– a period particularly relevant for prevention because it is generally before the onset of neurodegeneration. In
addition, this research addresses actor and partner effects within committed relationships to test whether the
protective effect of Interpersonal Conscientiousness extends from one member of the couple to the other. This
work will lead to new knowledge on how Interpersonal Conscientiousness promotes healthier cognitive aging
and will point to new prevention and intervention targets for promoting healthier cognitive aging across adulthood
to support better outcomes in older adulthood.

Public health relevance
Project Narrative Alzheimer’s disease and other dementias are a critical public health crisis because there are limited effective interventions to prevent, slow, or stop disease progression. Conscientiousness is a personality trait that is associated consistently with lower risk of cognitive impairment, but the mechanisms that explain why Conscientiousness is protective are not well understood. Identifying the processes through which Conscientiousness contributes to daily cognition and cognitive decline is critical to develop effective prevention and intervention strategies to promote healthy cognitive aging.